A chemical genetics approach to defining the role of iron metabolism in ferroptosis regulation

Ferroptosis, a form of regulated cell death characterized by the lethal buildup of lipid peroxides in cell membranes, is distinct from other known cell death mechanisms such as apoptosis, necroptosis, or necrosis. Its involvement in various physiological and pathological processes, including tumor suppression, immune surveillance, and ischemic organ injuries, underscores its significance. Despite its importance, understanding the intricate interplay between iron metabolism and ferroptosis remains a challenge. This gap persists partly due to the lack of efficient tools for monitoring cellular iron levels in live cells. To address this challenge, we engineered a cell line, 293T-5IRE, expressing an advanced reporter construct that allows tracking of changes in the labile iron pool (LIP) within live cells. Unlike conventional fluorescence dyes, this reporter system offers enhanced specificity and sensitivity in detecting cellular iron levels. Leveraging this tool, we aim to uncover cellular mechanisms and chemical agents influencing LIP levels and ferroptosis sensitivity. Our overarching goal is to elucidate the molecular mechanisms governing ferroptosis regulation by iron metabolism genes and their implications in physiological and pathological contexts. This proposal focuses on investigating the molecular mechanism of iron regulatory protein 2 (IRP2) on ferroptosis regulation and determining the role of salinomycin-induced lysosomal changes in modulating ferroptosis sensitivity. To address these two questions, we set two specific aims: 1) Elucidating ferroptosis resistance mechanisms by IRP2 knockout. We will investigate the impact of IRP2 perturbation on iron metabolism and ferroptosis sensitivity. By analyzing changes in the expression of iron metabolism genes and exploring potential alterations in the hypoxia-inducible factor alpha (HIFα) pathway, we aim to delineate how IRP2 knockout affects cellular capacity to handle LIP levels and confer resistance to ferroptosis. 2) Elucidating iron modulation and ferroptosis regulation by salinomycin treatment. We will explore the effects of salinomycin treatment on lysosomal status, iron metabolism genes, and NCOA4-mediated ferritinophagy to understand its mechanism of action in inducing ferroptosis. By examining whether lysosomal iron sequestration by salinomycin promotes ferritinophagy and enhances ferroptosis sensitivity, we aim to broaden our understanding of lysosomal involvement in ferroptosis regulation. This project fosters interdisciplinary collaboration and provides valuable research opportunities for undergraduate and graduate students at St. John’s University. By engaging in high-quality biomedical research, these students will gain invaluable skills and insights, paving the way for future careers in the field. In summary, our proposed research endeavors to unravel the intricate relationship between iron metabolism and ferroptosis, shedding light on novel therapeutic targets and mechanisms underlying cell death regulation in health and disease.

Public health relevance
PROJECT NARRATIVE Ferroptosis, a unique form of programmed cell death characterized by the lethal buildup of lipid peroxides in cell membranes, stands apart from conventional cell death modalities like apoptosis and necrosis. With involvement in diverse physiological and pathological processes, including tumor suppression and immune surveillance, ferroptosis has garnered attention for its potential therapeutic implications. While two primary mechanisms initiate ferroptosis, involving the inhibition of glutathione peroxidase 4 (GPx4) and system xc-, iron emerges as a central player in regulating this process. However, despite its significance, the precise role of iron metabolism in ferroptosis remains poorly understood, partly due to limitations in tracking metabolically active iron levels in live cells. To address this, a novel cell line, 293T-5IRE, was developed, allowing for the monitoring of labile iron pool (LIP) levels in live cells. This innovative approach aims to unravel cellular mechanisms and chemical probes influencing ferroptosis sensitivity. Our long-term goal is to elucidate the molecular mechanisms underlying ferroptosis regulation by iron metabolism genes and their implications in various conditions. The objective of this research project is: 1) to investigate into the role of iron regulatory protein 2 (IRP2) in ferroptosis regulation and 2) to determine the mechanism of salinomycin-induced lysosomal ferroptosis. Through comprehensive examination and pursuit of these two goals, this project aims to advance our understanding of ferroptosis regulation and foster the next generation of biomedical researchers.